Cannabidiol (CBD)-only use in Pregnancy and Perinatal Outcomes

PROJECT SUMMARY/ABSTRACT
Prenatal cannabis use is prevalent and associated with several adverse consequences for the mother and
offspring. Cannabis includes many compounds, including cannabidiol (CBD; a phytocannabinoid of the flower
cannabis sativa) and associations between specific cannabis compounds and maternal/child outcomes are
lacking. Specifically, little is known about CBD-only product use during pregnancy, despite the increase in
availability and acceptability of CBD over the past decade. We address this gap by addressing the following
aims: Aim 1: Estimate the prevalence of CBD use overall and by trimester in a clinical sample pregnant women
receiving prenatal care at the University of Colorado; Aim 2: Characterize women who use CBD and/or cannabis
during pregnancy (socio-demographics, mental health profiles, physical health concerns and cannabinoid use
behaviors and risk perception); and Exploratory Aim: Describe the pregnancy- and birth-related outcomes
associated with prenatal CBD use. Using an observational study design, we will study pregnant individuals in
their third trimester receiving care at University of Colorado perinatal clinics (n=800). All participants will complete
an electronically delivered survey, donate a one-time blood sample for analysis of cannabinoids (via liquid
chromatography-mass spectrometry), and consent to chart review of electronic medical records (EMR) once
their baby is born. Participants will be categorized into one of four groups: a) using CBD-only products, b) using
cannabis, c) using both CBD-only products and cannabis, and d) using neither substance during pregnancy. We
will assess prevalence of CBD-only product and cannabis use during pregnancy both at any time and by trimester
based on both the survey responses and blood sample analysis [Aim 1]. Further, the survey will assess
participants’ use patterns, mental and physical health concerns, demographics, and pregnancy-related concerns
[Aim 2]. We will review EMRs of all participants after the birth of their children to understand pregnancy- and
birth-related outcomes associated with CBD-only product use, whole cannabis use, and CBD-only product plus
cannabis use [Exploratory Aim]. Understanding associations between CBD and pregnancy- and birth-related
outcomes will be an important step in identifying potential safety concerns related to CBD use in pregnancy. The
PI works with an experienced team of mentors (Drs. Joseph Sakai, Susan Mikulich, Ashley Brooks-Russell, M.
Camille Hoffman, and Sharon Hunter) and will pursue training relevant to this proposal including: (1) clinical
research skills (survey design, study implementation, grant writing), (2) cannabinoids’ effects on early human
development (3) assessment of perinatal and infant research outcomes, (4) statistical expertise in longitudinal
analysis, causal analysis, (5) research presentation skills, (6) manuscript writing skills, and (7) engagement in
professional development opportunities. The training, mentorship, collaborative relationships, and results of this
project will serve as important steps to pursue an R01 grant and transition to research independence.

Public health relevance
PROJECT NARRATIVE Cannabidiol (CBD; a phytocannabinoid of the plant Cannabis sativa) has gained popularity, availability, and acceptability over the past decade, representing a multi-billion-dollar industry in the United States. There exists a critical barrier in the understanding of the possible adverse consequences of CBD-only product use in pregnancy in a human clinical population. Our study will address this barrier by assessing the prevalence of CBD use during pregnancy in a clinical sample, characterizing the population reporting use, and describing the associated pregnancy-related and birth-related outcomes.